Core A: Administrative Core

The primary function of the Administrative Core (Core A) is to provide the overall coordination of logistical and financial components of the Program Project, as well as to serve as an administrative structure that initiates and facilitates harmonization between the three projects and their supporting Cores. To serve these two interrelated functions, Core A has the following objectives: 1. Facilitate the complex interdepartmental and inter-institutional coordination of the various aspects of research administration. Core A will serve as the central liaison with departmental, administrative, and institutional oversight offices of both participating universities. 2. Ensure appropriate fiscal management of the Program Project by maintaining the records and accounting for all expenditures, maintain personnel records, prepare all required narrative and fiscal reports to ensure transparency of expenditures, communicate changes in fiscal matters in a timely manner to the Project and Core PIs and their respective units as required. 3. Prepare the annual Progress Report and applications supplemental funding for the Program project when appropriate. 4. Organize the bimonthly meetings of the Project leaders, co-investigators and internal Steering Committee, monthly teleconferences and quarterly meetings of the study coordinators (projects and cores), the annual meetings of the External Review Committee, the visits of external consultants, and bimonthly seminars that will include other collaborators and trainees associated with the Program Project. 5. Coordinate recruitment efforts of the human participants for Projects 1 and 2. 6. Promote intellectual discourse among the Projects, and facilitate the interaction with other funded programs within and outside of our institutions in order to maximize the impact of the Program Project to the scientific community. Overall, Core A will ensure that the scientific output of the Program Project is greater than the sum of the contributions of the individual projects.